A next-generation meningococcal serogroup B vaccine with improved effectiveness for all age groups

Abstract
Neisseria meningitidis is a major cause of meningitis and septicemia. Serogroup B (MenB) strains account
for most cases of invasive disease in infants and teenagers and nearly all U.S. college outbreaks. The MenB
capsule cross-reacts with host antigens, which precluded development of a capsular-based MenB conjugate
vaccine. Two manufacturers developed MenB vaccines that target protein antigens. Both contain recombinant
meningococcal Factor H binding protein (FHbp) and are licensed in the U.S. for teenagers and young adults but
not for infants and young children, the age groups at greatest risk. OMVax, Inc. is developing an improved
MenB vaccine for all age groups, including infants and young children. We have shown that binding of host
complement Factor H (FH) to FHbp vaccines decreases protective antibody responses and that immunization of
healthy young adults with a licensed MenB vaccine can elicit autoantibodies to FH, which may pose safety
issues. The OMVax vaccine uses proprietary native outer membrane vesicle (NOMV) technology with
genetically attenuated endotoxin that preserves native structures, combined with over-expressed mutant FHbp
antigens with low binding to FH. In infant macaques, a prototype NOMV-FHbp vaccine elicited greater
protection as reflected by broader and higher serum bactericidal activity (SBA) titers than a licensed MenB
vaccine and, unlike the licensed vaccine, did not elicit anti-FH autoantibodies. The OMVax vaccine also protects
against non-B strains causing epidemics in Africa. Our hypotheses are that the OMVax vaccine is more
effective and better tolerated than currently licensed MenB vaccines and that it will decrease nasopharyngeal
colonization and thereby provide community protection, a key limitation of current MenB vaccines. In Aim 1 we
will develop production strains (one each with over-expressed FHbp from sub-family A or B) for GMP-compliant
process and formulation and development of analytical methods suitable for release of Phase 1 vaccine
product. We will characterize research vaccine lots for immunogenicity studies in mice, toxicology in rabbits and
stability testing in vitro and with mouse potency assays. The data will allow preparation of SOPs and batch
record production to produce a lot of vaccine suitable for Phase 1 human testing. In Aim 2, we will establish
human complement SBA methods for demonstrating vaccine efficacy. Strain susceptibility to anti-FHbp SBA
can be affected by variations in both FHbp amino acid sequence and level of expression, and we will develop
assays using 4 to 8 epidemiologically relevant MenB strains with different FHbp sequence variants and
expression levels. The assays will be used to assess immunogenicity of NOMV-FHbp research lots in mice and,
subsequently, for GLP-compliant testing of Phase 1 human sera. The proposed studies will help predict
coverage of relevant MenB strains and enable NOMV-FHbp to undergo safety and immunogenicity testing in
healthy adults and, subsequently, in adolescents and younger age groups, including infants, necessary for
licensure of what OMVax anticipates to be a more effective and safer MenB vaccine for all age groups.

Public health relevance
Project Narrative Currently, there is no licensed vaccine in the US to prevent disease caused by Neisseria meningitidis serogroup B (MenB) strains in those less than 10 years old, the age group at greatest risk of developing meningococcal meningitis and sepsis. OMVax is developing a MenB vaccine for use in all age groups including infants and young children. The new vaccine also covers epidemic non-B strains from Africa, and uses proprietary technology based on native outer membrane vesicles prepared from mutant MenB strains with genetically attenuated endotoxin and over-expressed antigens to elicit broadly protective antibodies.